Conditional genetics and precision genome editing resources for Zebrafish

The overarching goal of this proposal is to create conditional gene animal resources for modeling human
health and disease in zebrafish through improved genome editing tools. Zebrafish (Danio rerio) is second only
to mouse as the most commonly published model system for human health. In 2023, NIH supports over 150
Principal Investigators in >200 Research and Resource Zebrafish projects (>$80 million) across 19 institutes.
Zebrafish possess high fecundity for genetic studies and optically clear embryos for live imaging and
visualization of developmental processes. Readily accessible methods have been established to modify gene
expression or edit the genome by injection of reagents into the single cell embryo. Zebrafish is increasingly
used for post-embryonic and adult models of disease and regeneration, requiring strategies for inducible
genetic manipulation with tight spatial and temporal control across the lifespan. The ability to fully utilize this
powerful animal model is limited by a lack of tools for tissue and cell-type specific gene functional studies,
reproducible and accurate transgene expression, and reliable integration of nucleotide variants and short
sequences into the nuclear genome. Epigenome regulation and energy metabolism are rapidly emerging areas
impacting development, disease, and regeneration, yet few zebrafish genetic alleles are available to study
either in zebrafish. Moreover, the ubiquitous expression of epigenetic and nuclear mitochondrial genes
requires conditional alleles to model tissue and organ specific pathologies associated with these fundamental
biological processes. For zebrafish to remain at the forefront of animal models that address the research
mission of institutes across the NIH, innovative methods are needed for precision genome editing and
expanding the conditional genetic toolbox to these understudies areas. Building on our pioneering strategies in
zebrafish genome editing, the improvements and conditional genetics resources we propose to develop here
will have a significant, lasting impact on zebrafish. We propose the following aims: Aim 1. Expand the
zebrafish community resource for Cre recombinase conditional gene studies to established fields of
zebrafish studies (embryonic development, major tissues and organ systems) and understudied, rapidly
emerging areas (epigenetics, mitochondrial biology). Aim 2. Further develop and improve methods for
precision targeted integration to increase the accessibility of our GeneWeld and DonorGuide methods for
integration of long DNA fragments and short sequences. Aim 3. Continue development and distribution of
targeted integration resources to the zebrafish community through seminars, conferences, social media, and
virtual and hands on training. We expect by the end of the funding period to significantly expand our Cre and
conditional allele resource. Our methods to improve GeneWeld and DonorGuide precision genome editing in
zebrafish will be widely applicable, given the near universal application of CRISPR genome editing in model
and non-model systems.

Public health relevance
The central goal for this application is to provide CRISPR/Cas methods and resources for conditional gene studies and improved precision genome editing to enhance zebrafish animal models for biomedical research. We expect by the end of the funding period to significantly expand our Cre and conditional allele resource to established fields of zebrafish studies (embryonic development, major tissue and organ systems) as well as understudied, rapidly emerging areas (epigenetics, mitochondrial biology) to facilitate new zebrafish models of human health across the lifespan. Our methods to improve GeneWeld and DonorGuide precision genome editing in zebrafish will be widely applicable, given the near universal application of CRISPR genome editing in model and non-model systems.